COMPARISON OF PRODUCTION AND METABOLISM OF TESTOSTERONE IN ETHNIC MEN

Compares the differences in metabolism, production and conversion rates of testosterone to metabolites in Caucasian and Chinese men for use of hormonal approaches in the development of male contraceptives.